Acquisition of a Triple Quadrupole Mass Spectrometer

Project Summary
Jackson State University (JSU) is a historic black institution of higher learning that is
dedicated to advancing STEM education mainly for local students in Mississippi. Aligning
with this commitment, the Department of Chemistry, Physics and Atmosphere Science
seeks funding to acquire a triple quadrupole mass spectrometer. This acquisition aims to
enhance the research and educational capacity at JSU and to boost JSU undergraduate and
graduate students’ participation in multidisciplinary research.
The triple quadrupole mass spectrometer will be used standalone for direct infusion
ESI-MS/MS applications and seamlessly integrated with a liquid chromatography system
recently acquired in 2023 for UPLC-MS/MS applications as well. This instrument setup will
provide the essential UPLC-MS/MS research capability on the JSU campus for the first time.
The triple quadrupole UPLC-MS/MS system with six major users will play pivotal roles in
multiple research projects encompassing quantitative bioassays, biochar for pollutants’
removal, solar cells, functional nanomaterials for bioimaging, water in dental hard tissues,
and breast tumor heterogeneity and metastasis. In addition, the instrumental support
extends to educational initiatives, including the teaching of Biochemistry and Instrumental
Analysis courses.
The proposed instrumentation has robust backing from the institution such as
support for infrastructure, supplies, and ongoing maintenance. The acquisition of the triple
quadrupole mass spectrometer represents a significant step towards enhancing JSU's
research capabilities and fostering a dynamic environment for cutting-edge research and
education.

Public health relevance
Project Narrative The goal of this project is to enhance the research and educational capacity of Jackson State University through the acquisition of a triple quadrupole mass spectrometer. This state-of-the-art instrument will be used in multiple research projects for quantification and identification of small molecules, peptides, oligonucleotides, etc. It will also be utilized in teaching undergraduate Chemistry and Biochemistry courses, including Biochemistry and Instrumental Analysis. The requested instrument is a Shimadzu LCMS- 8045 triple quadrupole mass spectrometer and LabSolutions software.